Antibody-dual drug conjugates for eradicating triple-negative breast cancer with heterogeneity

ABSTRACT
Triple-negative breast cancer (TNBC) is an aggressive and refractory subtype of breast cancer for which
limited clinical options are currently available. Although initially responsive to platinum-based neoadjuvant
chemotherapy, patients with metastatic TNBC rarely survive 5 years after diagnosis. Most TNBC tumors
consist of heterogeneous cell populations with different gene expression profiles. This heterogeneity
contributes to drug resistance, early relapse, and therapeutic failure. Although extensive research efforts have
made a few clinical options available, developing therapeutics that can effectively eradicate a broad range of
TNBC cell populations remains a challenge. Antibody-based drugs such as antibody-drug conjugates (ADCs)
are the most promising targeted therapeutic modality for treating TNBC. Trophoblast cell-surface antigen 2
(TROP2) is a protein overexpressed in more than 80% of TNBC, representing a promising molecular target.
Recently, Sacituzumab Govitecan (Trodelvy), a TROP2-targeted antibody-drug conjugate (ADC), was granted
accelerated approval for the third or later line of treatment of metastatic TNBC. However, TNBC often relapses
after continuous treatment; the intratumor heterogeneous expression of TROP2 and drug resistance induced
by its payload SN-38 likely contribute to poor clinical outcomes. In addition, patients treated with Trodelvy often
suffer from adverse effects, including neutropenia. Thus, enhancing the efficacy, expanding the target scope,
and ensuring the safety of this drug class remain critical clinical needs to develop safe and effective therapies
for patients with heterogeneous TNBC. We have developed novel ADC technologies, including: 1) peptide
linkers for maximizing ADC therapeutic index, and 2) bifunctional chemical spacers and a site-specific
conjugation for generating homogeneous ADCs containing two distinct payloads (termed dual-drug ADCs).
Specifically, our dual-drug ADCs containing two different antimitotic agents showed greatly improved safety
and efficacy in mouse models of HER2-low refractory breast cancer compared with the FDA-approved ADCs
Kadcyla and Enhertu. Based on this success and our preliminary data, we hypothesize that optimally designed
anti-TROP2 dual-drug ADCs effectively eradicate a broad range of solid and metastatic TNBC tumors. In Aim
1, we will investigate how our novel linkers are processed in cancer and normal cells by cell-based assays,
proteomic analysis, and in vivo biodistribution analysis. In Aim 2, we will synthesize novel DNA-alkylator
payloads and potentiators with varying chemical properties. We will then prepare a series of anti-TROP2 dual-
drug ADCs varying in the combination and the number of drugs conjugated to the antibody. In Aim 3, we
evaluate the dual-drug ADCs for toxicity efficacy in TNBC mouse models. Successful completion of this project
will lay the foundations for this novel drug class with the potential to overcome heterogeneity and resistance of
TNBC, which may eventually revolutionize current therapeutic strategies for this devastating disease.

Public health relevance
PROJECT NARRATIVE Antibody-drug conjugates (ADCs) are the most promising drug class for the treatment of triple-negative breast cancer (TNBC). However, further improvement is critically needed to benefit more patients with TNBC. The goal of this project is to generate novel ADCs with substantially improved efficacy and safety that can effectively eradicate a broad spectrum of solid and metastatic TNBC tumors.